QBS10072S for the Treatment of Brain Metastatic Triple-Negative Breast Cancer

PROJECT SUMMARY
Quadriga Biosciences’ new small molecule therapeutic, QBS-72S, combines a DNA alkylating moiety with
an amino acid analogue that leverages the L-Type Amino Acid Transporter 1 (LAT1) to achieve transport across
the blood brain barrier (BBB) and selective accumulation in tumor cells. Results from preclinical studies suggest
QBS-72S is likely effective against brain metastases (brain mets) resulting from multiple cancer types, including
triple negative breast cancer (TNBC). Currently, treatment for brain mets in patients with TNBC is limited to
surgical intervention or radiotherapy, and drug development has been unsuccessful due to the challenge of
transporting effective agents across the BBB. In this Direct-to-Phase II SBIR, Quadriga proposes to conduct a
Phase 2a proof-of-concept clinical trial in patients with brain mets resulting from TNBC to test the safety and
efficacy of QBS-72S using a Simon’s two-stage design. Data from this study is expected to inform the design of
a pivotal Phase 3 trial. Aim. Evaluate the safety and efficacy of QBS-72S in TBNC patients with brain
metastases. Up to 25 patients with TNBC and brain mets will be identified by physicians at Stanford University
and its referral network based on contrast MRI of the brain. Participants will be treated with the maximum
tolerated dose (MTD) of QBS-72S administered intravenously every four weeks for up to 2 years. Tumor growth
will be assessed by MRI the day prior to each administration for the first four months and every other month
thereafter. The primary endpoint is objective response rate (i.e., the percentage of patients with ≤ 25% growth
in tumor size, no change in tumor size, or reduction in tumor size) at 3 months. Secondary endpoints include
overall survival, length of progression-free survival, response of systemic disease, adverse events, and changes
in lab-assessed patient parameters. Milestones: Using a Simon's two-stage Minimax design, if two or more of
the first 15 evaluable TNBC patients treated with QBS-72S achieve an objective tumor response
, the study will
enroll 10 additional patients. If six or more patients (out of 25 total) have an objective tumor response within 3
months after initiating therapy, we will meet with the FDA to discuss the design of a registration trial for patients
with brain mets resulting from TNBC. Impact—Successful completion of these studies will establish the
foundation for a subsequent Phase 3 clinical trial. If QBS-72S proves efficacious in treating brain mets in patients
with TNBC, it would be the first chemotherapeutic agent available specifically for this population. Findings of
efficacy would also support further exploration into using QBS-72S to treat patients with other brain metastatic
cancers, including lung cancer and melanoma. In addition, since LAT1 is highly expressed on many other forms
of aggressive cancer, QBS-72S may be suitable for treating both systemic cancers and CNS metastases,
especially in diseases like TNBC where there are few therapeutic options.

Public health relevance
PROJECT NARRATIVE This project will test the safety and efficacy of Quadriga’s new small molecule drug, QBS72S, in a clinical trial of patients with triple-negative breast cancer (TNBC) with brain metastases (tumor cells that have spread to the brain). TNBC is the most aggressive subtype of breast cancer: almost half of all women with TNBC develop brain metastases, and those who do typically survive for only three to six months longer. If QBS-72S proves effective in treating brain metastatic TNBC patients, it will hold promise for treating patients with other brain metastatic cancers, including lung cancer and melanoma.